Cognitive Neuroscience of Development and Aging (CONDA) Center

Contact PD/PI: Wilson, Tony W
Abstract/Summary: Overall Component
This application for a Center of Biomedical Research Excellence (COBRE) would initiate a formal Center to lead,
support, and expand neuroimaging and clinical cognitive neuroscience research in Nebraska, with an emphasis
on lifespan development. It is an opportune moment for human neuroscience research in the Omaha community,
regionally, and across the world, with many new research tools and government initiatives intended to illuminate
the next frontier of biomedicine. The proposed Cognitive Neuroscience of Development and Aging (CONDA)
Center will provide critical resources and support to faculty from four institutions: the University of Nebraska
Medical Center (UNMC), the Boys Town National Research Hospital, the University of Nebraska – Omaha, and
Creighton University. The Administrative Core of the CONDA Center will be housed at UNMC, which is less than
two miles from each of the other institutions, and will be comprised of Training, Evaluation, Engagement,
Administration, and Mentoring areas (i.e., the TEEAM Core). The new CONDA Center will also include a state-
of-the-art Neuroimaging Acquisition and Analysis Core, as well as extensive support for four primary COBRE
research projects led by a promising group of NIH-defined early-stage investigators. Upon initiation of the Center,
the TEEAM Core would immediately implement a series of new programs that are designed to develop human
cognitive neuroscience on the CONDA Campus and across the region. The TEEAM Core would also rapidly
implement a comprehensive research support structure that includes the Neuroimaging Core facility, training
opportunities, pilot projects and mini-grants programs, a new seminar series, postdoctoral fellowships, intern-
ships for growing temporary and long-term laboratory staffing, and a participant registry to enhance recruitment.
In parallel, the TEEAM Core would promote the successful launch of the primary COBRE research projects and,
through a mentoring network approach, implement a career development and evaluation support system to
monitor progress and ensure Junior PIs and their mentoring teams reach critical milestones. As per the new
research core, the Neuroimaging Acquisition and Analysis Core facility would be the only core dedicated to
human brain research in the state of Nebraska, and would provide regional scientists with state-of-the-art tools
for neuroimaging and neuromodulation, including research-dedicated MRI and MEG systems. The new Center
would also receive exceptional institutional support, including financial support for CONDA programs, major
equipment expenses, and Core staffing. The overall CONDA team includes an established group of PIs in neuro-
imaging, brain dynamics, aging, and brain and cognitive development, as well as a strong cohort of emerging
junior investigators using innovative cognitive and affective neuroscience methods to address major questions
in human neuroscience across the lifespan. These junior scientists were all hired in the past three years, and this
new wealth of concentrated local expertise has primed us for a trajectory of accelerated development of neuro-
science and neuroimaging toward national prominence, an aim for which the new CONDA Center will be integral.
Page 85
Project Summary/Abstract

Public health relevance
PROJECT NARRATIVE Global cerebral ischemia arises as a consequence of cardiac arrest and affects ~200,000 Americans each year, however, an effective treatment for neurodegeneration and cognitive deficits associated with global ischemia remains an unmet medical need. Here, we propose our team research consisting of team members with different expertise which allows us together to ask questions that we cannot address individually. We will examine the ability of novel small molecule TREM1 inhibitors to prevent global ischemia-induced neuronal death and cognitive deficits and provide transcriptome profiles in post-ischemic hippocampal CA1 at the level of specific neural cell populations or single cells.